The CHARMED model: a multimorbidity simulation model for people aging with HIV

PROJECT SUMMARY
Older people with HIV (PWH) in the United States are a rapidly expanding group and are at increased risk for
cognitive impairment despite virologic suppression. While declining cognitive function is a critical contributor to
reduced quality of life and currently affects 20-50% of PWH, there are no effective diagnostics or therapeutics
to predict and track disease progression and to mitigate morbidity in PWH with cognitive impairment on
antiretroviral therapy. As more providers in HIV and primary care clinics care for an aging population with HIV,
we recognize the need for minimally-invasive diagnostics such as blood-based biomarkers to assess cognitive
function. Blood-based biomarkers that can detect proteins produced by neurons or glial cells are poised to
become clinically available as part of a repertoire of diagnostic tools in memory clinics. Assessing the
diagnostic performance of these blood biomarkers in predicting cognitive impairment and its progression in
large cohorts of older PWH on antiretroviral therapy is critically important.
In the parent R01 (R01AG069575), the PI (Dr. Emily Hyle) and research team detailed methods for developing
and populating a simulation model of dementia and multimorbidity for the aging HIV population, the CHARMED
(Cognitive impairment, HIV, Aging, heaRt, MEntal health, and Dementia) model. In this administrative
supplement, the research team will leverage data and samples from the AIDS Clinical Trials Group (ACTG) to
investigate the ability of two plasma biomarkers, neurofilament light (NfL) and glial fibrillary acidic protein
(GFAP), to discriminate between older PWH (over age 45 years) on antiretroviral therapy who develop
cognitive impairment and those who remain free of cognitive impairment. These biomarkers are surrogates for
neuroaxonal injury and astrocyte proliferation, respectively, and are actively under investigation for other
neurological disorders, including cognitive decline in older people without HIV presenting to memory clinics. To
provide more accurate estimates of plasma NfL and GFAP levels for clinical interpretations, the team will
additionally determine the relationship between comorbidities frequently associated with cognitive function and
plasma concentrations of these biomarkers in PWH on antiretroviral therapy. Data generated from this
proposal will be used to expand the CHARMED model; the research team will then use the CHARMED model
to assess the implications of the range of test characteristics for these two biomarkers and examine the impact
and cost-effectiveness of a biomarker approach to diagnosis based on a range of costs per test among people
aging with HIV.

Public health relevance
PROJECT NARRATIVE Cognitive impairment is one of the critical manifestations of HIV in older adults, and better methods to predict cognitive impairment would be of substantial clinical value. This project will evaluate two blood biomarkers called neurofilament light and glial fibrillary acidic protein that can detect active brain injury and determine how well the blood biomarkers predict cognitive impairment in older people with HIV antiretroviral therapy. The overall goal is to understand how we can use these blood biomarkers to better evaluate for cognitive impairment in people aging with HIV on antiretroviral therapy.